Charge Transfer Study of DNA/MoS2 interface

Project Summary
Expansion of tandem DNA repeats cause more than forty genetically transferrable disorders,
which affect 4 million people every year. Current state-of-the-art diagnostic technologies for genetic
testing for length mutations have their own limitations such as clogging of protein nanopores, requiring
labelling steps, frequent false positive/negative results, or short basepair read length. To overcome the
limitations that hamper the current biomedical science, there is a critical need to develop new platforms
founded on thorough basic science. This AREA proposal involving mainly undergraduate researchers
investigates intrinsic character of tandem DNA repeats interfaced with MoS2 surfaces that may manifest
into label-free sensing platform for repeat mutations in future.
The PI hypothesizes that DNA repeats can produce sequence- and length-dependent charge
transfer signals due to the differential affinity of nucleobases for two-dimensional materials, i.e.
molybdenum disulfide (MoS2). This is the critical piece of information needed to confirm through a
rigorous study. Based on encouraging preliminary results, current project is designed to fundamentally
investigate DNA/MoS2 interfaces in detail by electrochemical and surface probe microscopy
techniques. In the specific aims, the PI plans to (1) investigate sequence-dependent charge transport at
TNR/2D nanomaterials interface, and (2) investigate their behavior with respect to sequence length. The
results will also be compared with concentration and conformations effects on the charge transfer
character.
This AREA proposal will expose the undergraduate researchers to high-quality research in
surface chemistry and materials science, which has ultimate application in biomedical research to
improve public health. Upon completion, we will be in better position to apply DNA/2D materials for
selective and sensitive detection of repeat mutations, which will ultimately improve the lives of millions
of individuals.

Public health relevance
Project Narrative Expansion of small nucleotide repeats in human gene cause almost forty genetically transferrable disorders. This AREA proposal involving undergrad students pitches a fundamental investigation of intrinsic charge transfer character of the interfaces comprising trinucleotide DNA repeats and molybdenum disulfide surface to explore unique sequence-dependent signaling. The critical piece of information is needed to ultimately develop a simple, sensitive, and label-free detection platform for DNA length mutations, which affect 4 million individuals every year.